Advancing Apoptosis-Inducing Agents as Host-Directed Therapy for TB

Mycobacterium tuberculosis (Mtb) is known to subvert host immune responses to establish infection and cause
tuberculosis (TB) disease. Thus, boosting host immune responses via host-directed therapy (HDT), as adjunctive
treatment to traditional antitubercular regimens, is an attractive strategy. Apoptosis is an evolutionarily conserved
pathway for genetically programmed cell death, and the successful execution of macrophage apoptosis following
infection with Mtb serves as an important innate immune defense. However, Mtb has evolved virulence strategies
to subvert macrophage apoptosis and induce necrosis, thereby promoting its survival and dissemination of
infection. Mitochondria mediate intrinsic apoptosis and can participate in the amplification of extrinsic apoptosis
signaling, as well as contribute to alternate cell death modalities. Previously, we observed alterations to canonical
apoptosis activation in Mtb-infected macrophages, manifested by mitochondrial translocation of anti-apoptotic
XIAP in parallel with incomplete mitochondrial apoptotic pore formation. Our data are consistent with those of
other groups suggesting that Mtb interferes with the central process of intrinsic apoptosis signaling, namely
mitochondrial outer membrane permeabilization (MOMP). In support of an apoptosis-inducing HDT approach for
TB, we and others found that promotion of the intrinsic apoptosis pathway through pharmacological inhibition of
the anti-apoptotic factors MCL-1 and BCL-2 reduces intracellular Mtb growth in macrophages and in vitro
granulomas. We have shown that adjunctive treatment with an activator of caspase-3 enhances the bactericidal
and sterilizing activities of the first-line anti-TB regimen in a murine TB model. Recently, we found that adjunctive
treatment with a clinical-stage inhibitor of BCL-2/BCL-XL enhances the bactericidal activity of the first-line
antitubercular regimen and decreases the size and necrosis of lung lesions in a murine model of human TB-like
pathology. In addition, enhancement of both extrinsic and intrinsic apoptosis through inhibition of inhibitor of
apoptosis (IAP) family proteins augments the clearance of Mtb in the lungs of chronically infected mice. In the
current proposal, we will identify apoptosis-inducing HDT agents of clinical relevance that can be exploited to
enhance macrophage-based clearance of Mtb. We will employ a combination of targeted genetic and
pharmacological approaches and integrate state-of-the-art knowledge on MOMP regulation to comprehensively
characterize mechanisms of action involved in their antitubercular HDT activity. Selected apoptosis-inducing
HDT agents will be tested for their adjunctive ability to shorten the duration of curative TB treatment in a clinically-
relevant animal model. Our team combines significant expertise in TB pathogenesis, the mechanistic
investigation of apoptosis and alternative cell death modalities, single-cell microscopy and in vivo imaging, and
HDT development for TB. Our findings are expected to yield novel HDTs that can be tested in clinical trials for
their potential to shorten the duration of curative treatment and improve long-term lung function in patients with
drug-susceptible and drug-resistant TB.

Public health relevance
PROJECT NARRATIVE Host-directed therapies (HDTs) have the potential to significantly enhance current antibiotic regimens for tuberculosis (TB). Macrophages are the major host cell niche for Mycobacterium tuberculosis (Mtb) infection, and apoptosis of Mtb-infected macrophages, which is repressed by Mtb, constitutes an important innate defense mechanism against TB. The goal of this program is to identify clinically-relevant HDTs that maximize apoptosis induction in Mtb-infected macrophages, characterize their mode of action, and determine their potential to shorten the duration of curative treatment for drug-susceptible and drug-resistant TB in an animal model of clinical relevance.